Administrative Supplement (Undergraduate Summer Research Experiences) - Mitochondrial respiratory chain disease mechanistic and therapeutic modeling

PROJECT SUMMARY (PARENT GRANT). Mitochondrial respiratory chain (RC) diseases are highly morbid
energy deficiency disorders with remarkably heterogeneous etiologies and phenotypes across all ages and
systems, caused by pathogenic variants in > 350 different genes across both genomes. No cure, FDA-
approved, nor clinical trial-validated therapies exists for RC diseases. As one-size-fits-all, single therapy is
unlikely to benefit all patients, therapeutic modeling is essential to develop precision medicines that meaningful
improve health in distinct molecular, biochemical, or clinical RC disease subtypes. Specifically, pre-clinical
translational RC disease investigations in human patient cells and simple animal models may efficiently
identify potent therapeutic leads, and specific mechanistic targets, to meaningfully improve overall health. With
our unique collection of ‘matched’ nuclear gene-based RC disease model sets (for NDUFS2, NUBPL, SURF1,
FBXL4, C12ORF65, DLD) across 3 evolutionarily distinct species in C. elegans (worm, invertebrate), D. rerio
(zebrafish, vertebrate), and human patient fibroblasts in which we have validated a suite of novel
methodologies, we are strongly situated to further harness a multi-species modeling approach. Indeed, we
have established a highly productive research program in RC disease models to cross-validate multiple
mechanistic insights and identify promising new therapeutic leads for primary RC diseases. NIGMS R35 MIRA
support will enable focus of this basic and translational research program with demonstrated teaching
opportunities, as built over the past 14 years by an internationally-recognized investigator, to advance
precision Mitochondrial Medicine by identifying central disease mechanisms and lead therapeutic candidates
for diverse RC disease subtypes. Specifically, this translational research program will focus on harnessing RC
disease patient cell and simple animal models to investigate key questions across 2 overarching themes.
Theme 1 is Pathophysiology Investigations, involving 4 project areas: (i) Understanding the mechanistic basis
by which different organ pathophysiology predominates in distinct RC diseases, (ii) Developing sensitive
nanosensors to non-invasively quantify in vivo mitochondrial functions, (iii) Deciphering the functional
significance of novel post-translational modifications, including N-glycosylation, of mitochondrial proteins in RC
disease, and (iv) Determining which central nutrient- sensing signaling network (NSSN) node(s), and their
downstream biochemical pathways that regulate cellular proteotoxic stress, to therapeutically target in specific
RC disease subsets. Theme 2 is Therapeutic Modeling, involving 3 project areas: (v) Recognizing the optimal
nutritional therapies (macronutrients, vitamins, cofactors) to improve health and overall function in RC
disease, (vi) Harnessing translational animal and cellular models for high-throughput drug screening and lead
compound validation, to efficiently identify highly potent, safe, and precision therapies for distinct RC disease
subgroups, and (vii) Identifying whether primary RC disease treatments will improve health in disorders with
secondary (such as Trisomy 21) or acute RC dysfunction.

Public health relevance
PROJECT NARRATIVE (PARENT GRANT). Mitochondrial respiratory chain (RC) disease is a highly heterogeneous, multi-systemic genetic disorder affecting all organs and ages. Translational RC disease investigations in human cell and simple animal models may identify effective therapies, and specific mechanisms, to improve overall health.